Comprehensive Advancement in Research Education and Training for Social Determinants of Health (CARES)

PROJECT SUMMARY
This proposed R25 program, Comprehensive Advancement in Research Education and Training for Social
Determinants of Health (CARES), at the Yale University School of Nursing is designed to address existing
gaps in the education and training of nursing researchers in Social Determinants of Health (SDOH). The
purpose of this program is three-fold: First, orient emerging researchers to recognize, appreciate, and
incorporate into their research concepts and principles of SDOH that influence and shape individual and
population health. Second, research methods will be provided and developed toward disentangling multiple
policy and program influences and their health effects. Third, approaches will be shared and developed toward
structural interventions on these upstream factors as they influence health. The curriculum is intensive and
includes the development of academic and community networks which are designed to accelerate them
becoming established investigators. The program is aimed at nurse researchers who are under-represented in
the scientific community. The education and training activities are in three segments that surround an
intensive summer research residency. The first segment involves a monthly online introduction (over five
months) to key concepts and frameworks for SDOH research. The second is a month-long intensive in-
residence (in-person and hybrid) Summer Institute that delves into research method topics while networking
with and mentoring and culminating in a proposal concept development. The third segment is regular and on-
demand coaching with mentors and SDOH research community-building with CARES cohorts through
engagement in an active online network hub during and post-program. The outcome of the program is the
delivery of the SDOH research courses, with an expansion of a social network of researchers that manifests
peer-reviewed publications and competitive grant proposals. With our recruitment plan (via targeted social
network and professional and academic networks), we will host three training cohorts (6-8/cohort) of early
career nursing scholars, specifically including those from racial and ethnic minority identities. Eligibility and
selection for the program include the applicant’s research interest on SDOH research, evidence of institutional
support, and a match of CARES’ mentor and scholar’s interests. Evaluation includes ongoing assessment of
progress, mentoring, and productivity as reviewed by the Steering Committee and the External Advisory Board.
Innovative aspects of the program include a focus on interdisciplinary, simulation-based, and community-
based training and mentoring approach. The CARES program is grounded in the Healthy People 2030
framework and the NIH SDOH Research Framework and seeks to establish a robust foundation in SDOH
research, synthesize evidence across disciplines, enhance research methodology competencies, and cultivate
effective participant engagement and ongoing support strategies. Ultimately, the CARES program will empower
nurse researchers to conduct rigorous and impactful SDOH research and promote health equity for all.

Public health relevance
PROJECT NARRATIVE This R25 CARES program addresses gaps in social determinants of health (SDOH) education for nursing researchers, aiming to equip early career scholars, especially those from under-represented backgrounds, with comprehensive SDOH research fundamentals and methodologies. The program includes short courses, summer institutes, mentorship, and networking activities over three years for three cohorts. By fostering a supportive community, enhancing research proficiency, and promoting diversity, the program seeks to empower nurse researchers to conduct impactful SDOH research, contributing to the advancement of knowledge in the field.